BLRD Research Career Scientist Award Application

The overall goal of this Merit Review Research Career Scientist (RCS) Award is to recognize the contributions
of a non-clinician minority scientist to the VA-ORD and to the field of vascular biology. Roberto I. Vazquez-Padron,
Ph.D., F.A.H.A. is renowned expert in venous and arterial occlusive diseases seeking to revamp the field with
transformative and clinically relevant discoveries. He is currently a Senior Research Scientist, Miami Veterans
Affairs Healthcare System, and Tenured Professor at the DeWitt Daughtry Family Department of Surgery,
University of Miami Leonard M. Miller School of Medicine. He is also the current Director of Vascular Biology
Institute and founder of the University of Miami Vascular Tissue Biobank, a one-of-a-kind biorepository of human
arteries and veins which currently contains >2,000 specimens. Dr. Vazquez-Padron studies vascular occlusive
diseases like restenosis, atherosclerosis, and hemodialysis vascular access failure. His goal is to identify
therapeutic targets capable of reducing or inhibiting the inward remodeling associated with narrowing arteries
and veins after surgery. He has established a retro-translational program (from clinical science to basic research)
based on high-throughput omics that has made parading-shifting discoveries and reformulated our view of the
causes of venous stenosis following arteriovenous fistula creation. Since its inception in 2005, Dr. Vazquez-
Padron’s laboratory has been continuously funded from institutional and extramural sources including the
American Heart Association, Florida Department of Health, Stanley Glaser Foundation, the National Institutes of
Health, and the Veterans Affairs Health System. He has published >100 original articles (H-index of 32) in highly
regarded peer-reviewed journals like JCI, Nature Communications, JASN, AJKD, Kidney International, and
Atherosclerosis. Dr. Vazquez-Padron is frequently invited as speaker to national and international forums. He
also serves as reviewer and associate editor for prestigious journals and is currently a standing member of NIH
and VA scientific review groups. Dr. Vazquez-Padron, one of the most important and rewarding roles is that of
research mentor. He has successfully trained young faculty members (three current K-awardees), graduate
students, postdoctoral fellows, and medical residents. He is currently Co-Director of the University of Miami
Kidney Innovative and Interdisciplinary Medical Education in Research Activities (UM-KIIMERA) T35 training
program to produce outstanding academic nephrologists, including clinical investigators and physician-scientists.

Public health relevance
Dr. Roberto I. Vazquez-Padron research network has the potential to help over 200,000 veterans who suffer from chronic kidney disease, and nearly 30,000 of them already require dialysis to save their lives. His landmark studies target the failure of the hemodialysis vascular access that remains the primary source of hospitalization and complication for these patients. His studies have identified the pathogenic molecules responsible for the failure of the most common vascular access, the arteriovenous fistula. Outcomes from his research represent a breakthrough that will provide new therapeutic targets and strategies to improve vascular access dysfunction, reduce medical complications, and, ultimately, save lives.